ALIADOS: Advanced training in Latino multi-level Intervention reseArch for DOctoral Scholars

PROJECT SUMMARY
Latine populations in the U.S. continue to be disproportionately impacted by health disparities, including those
related to chronic and infectious diseases. These disparities are the result of long-standing systemic factors
including social determinants of health and multi-level factors that contribute to increased risk of disease in the
Latine population. Addressing these disparities requires increasing the diversity of researchers by creating
opportunities for rigorous and tailored training in cutting-edge Latine health disparities and health equity
research, including multilevel prevention interventions and related methodologies. This is a new application in
response to the ADVANCE Predoctoral T32 Training Program to Promote Diversity in Health Disparities
Research, Prevention Interventions, and Methodology (RFA-OD-23-018). This application proposes a new T32
doctoral training called ALIADOS (Advanced Training in Latine multi-level Intervention reseArch for DOctoral
Scholars; ‘aliados’ is a Spanish term for ‘allies’). The ALIADOS program will focus on training diverse doctoral
students in Latine health and health disparities and rigorous methods for conducting multilevel-preventive
interventions research. While the T32 focuses on Latine health and health disparities, the skills, and
competencies the T32 scholars will achieve through the program are transferable to diverse contexts and other
populations experiencing health disparities. Thus, the program will have wider reaching benefits to health
disparities research more broadly. The overall program goals are to: 1) Identify, recruit, and retain promising
T32 doctoral scholars, with an emphasis on underrepresented minority students and those committed to working
in Latine health disparities and health equity research, 2) Provide rigorous didactic and hands-on training in
Latine health disparities and health equity research, multi-level prevention interventions and statistical methods
to a diverse cadre of doctoral students in the Joint Doctoral Program in Public Health at SDSU and UCSD through
a comprehensive training program, and 3) Prepare scholars for the successful transition to research
independence and promote next steps in their career development.

Public health relevance
PROJECT NARRATIVE Latine populations in the U.S. continue to be disproportionately impacted by health disparities, including those related to chronic and infectious diseases. Addressing these disparities requires increasing the diversity of researchers by creating opportunities for rigorous and tailored training in cutting-edge Latine health disparities and health equity research, including multilevel prevention interventions and related methodologies. This is a new application. This application proposes a new T32 doctoral training called ALIADOS (Advanced Training in Latine multi-level Intervention reseArch for DOctoral Scholars; ‘aliados’ is a Spanish term for ‘allies’) to traine diverse doctoral students in Latine health and health disparities and rigorous methods for conducting multilevel- preventive interventions research.